Developing Synthetic Enzymes to Treat Inborn Errors of Metabolism

Project Summary.
The severe, acute, and chronic developmental and neurological impacts seen in branched chain ketoacid
dehydrogenase deficient Maple Syrup Urine Disease (BCKD-deficient MSUD) and isovaleryl‐CoA
dehydrogenase deficient Isovaleric Acidemia (IVD-deficient IVA) seen in newborns are due to the presence of
high concentrations of leucine, isoleucine, and valine in their system. Patients with these disorders are limited
to manage their condition though a low-protein diet and nutrient supplementation, which is often inadequate,
difficult to adhere to, and can still lead to metabolic decompensation. Management strategies include reduction
and restriction of toxic metabolites and substrates, promotion of anabolism and stimulation of residual enzyme
activity along with activation of amino acid and ketoacid scavenging pathways. Even then, the quality of life of
patients is poor, as is for their caregivers since patients need to be monitored closely to avoid metabolic crisis
precipitated either by infection, diet, or other reasons. Thus, there is significant need for new medications that
can benefit infants, children, adolescents, and adults. This work is based on the hypothesis that high systemic
concentrations of offending amino acid(s) in patients can be reduced using high activity enzymes, in a manner
like how Pegvaliase reduces phenylalanine concentrations in phenylketonuria (PKU) patients. Core to this work
is implementation of a twofold approach that combines experimental directed evolution techniques and
computations enzyme design.

Public health relevance
Project Narrative. This overall goal of this work is to develop synthetic enzymes for the treatment of inborn errors of metabolism (IEM) associated with branched chain amino acids like maple syrup urine disease (MSUD) and isovaleric acidemia (IVA). The focus will be on using a two-pronged approach comprising of experimental directed evolution and computational protein design to create ammonia-lyase enzymes that are able to non-oxidatively deaminate leucine, isoleucine, and valine.